ACTG 388 TRIAL OF EFZ OR NFV WITH LAMIVUDINE/ZDV &INDINAVIR IN HIV INFECTION

This protocol is assessing the effect of different combinations of four protease inhibitors to achieve a plasma HIV RNA level below the limit of detection.